The AMPREDICT PROsthetics Decision Support Tool: using evidence to guide personalized prosthetic prescription and rehabilitation planning

Recent research has highlighted the challenges faced by the clinical rehabilitation team in providing a
personalized rehabilitation experience for patients undergoing lower extremity amputation due to chronic limb
threatening ischemia. These challenges include the prescription of personalized prosthetic componentry,
formulating the most appropriate prosthesis rehabilitation plans based upon the patient’s functional goals and
potential, and setting appropriate patient expectations by communicating clearly what level of prosthesis
mobility they will likely achieve. Though not the primary impetus behind prosthesis prescription justification
within the VHA, the traditional paradigm for a lower limb prosthetic prescription is largely driven by the
providers best estimation of the patient’s future mobility outcome sometimes using K-levels or other analogous
mobility categories. The appropriate prosthetic componentry is then matched to the predicted mobility level.
This approach is wrought with challenges and clinicians do not have a lot of confidence in this process. There
is no evidence to back the clinician’s ability to predict future mobility. Current clinical practice guidelines also do
not offer adequate evidence or guidance to shape these decisions. The time of initial prosthesis evaluation is a
key time point in the amputation rehabilitation continuum that can profoundly influence future functional and
quality of life outcomes. Lower extremity amputations are a major health care concern within the VA Health
Care System. The VA Amputee System of Care (ASoC) is a national clinical program within Rehabilitation and
Prosthetic Services with the primary goal of enhancing the care and outcomes of Veterans with limb loss. The
ASoC is concerned with the most appropriate management of persons with limb loss to maximize function and
quality of life, as well as reducing health care disparities between regions and improving geographical access
to health care resources. To improve the rehabilitation clinician’s ability in setting rehabilitation mobility goals,
prescribing personalized prosthesis components to meet those goals, helping patients set appropriate
expectations, [and reassessing patient progress], we propose to develop the AMPREDICT PROsthetics (aka,
AMPREDICT PRO) decision support tool. This tool will use the AMPREDICT PRO prediction model output to
develop a calculator that will predict the probability that a patient will achieve each of the following mobility
levels 12 months after their prosthesis prescription: (1) wheelchair mobility only, (2) able to walk in the house,
(3) able to walk in the community short distances on even surfaces, and (4) ability to walk in the community
unlimited distances on several terrains. The tool will be developed and tested by VHA rehabilitation clinicians
from all geographic regions to help determine the methods of delivering the tool such as a website, smart
phone application, or the electronic health record, and to provide input on ways to ensure the tool will be
utilized and successfully implemented throughout the VHA medical system. In addition to assisting in
personalized prosthesis prescription and rehabilitation planning [and progress assessment, the tool will
generate a patient facing educational handout that will help them understand their predicted mobility level and
empower them with strategies to achieve the highest level possible.] The results of this research could be
incorporated within the Veterans Affairs and Department of Defense Amputation Clinical Practice Guidelines,
ASoC core tools, and accomplish one of the VA Health Information Strategic Recommendations for increased
decision support and analytic tools.

Public health relevance
Our goals for the AMPREDICT PROsthetics decision support tool are based on a conceptual model that assumes each patient presents with a composite of risk factors from several important health domains and these factors when considered together have a profound impact on a patients future prosthesis mobility. A rigorously developed and validated prediction model will be converted into a calculator used by rehabilitation clinicians in the clinical environment to predict prosthesis mobility 12 months after prescription. Rather than relying on subjective estimates of future mobility, or relying on clinical experience alone, the decision support tool will provide the probability of achieving 4 levels of mobility in each individual patient. This predicted probability can be used for personalizing prosthesis prescription, assisting in rehabilitation planning, helping set patient expectations, [and reassessing mobility progress.]